Pharmacodynamics, Pharmacogenetics, Clinical Efficacy and Safety of Tradipitant for Functional Dyspepsia

ABSTRACT
30 lines (currently 30)
Upper gastrointestinal symptoms may result from gastric dysfunction including reduced gastric accommodation
and gastric hypersensitivity, and may cause functional dyspepsia (FD), a very common cause of substantial
morbidity estimated to affect 10% of the population. FD manifests as abdominal pain/discomfort for at least
three days per week which may be associated with eating. An estimated 40% of patients with this symptom
complex consult their physicians, negatively influencing their workplace attendance and productivity with
overall economic impact of more than $18 billion in 2009. Development of effective treatments of these
disorders is desirable, given significant unmet medical need. Systematic reviews and meta-analyses of the
literature have shown low levels of efficacy with current treatments which include proton pump inhibitors, H
pylori eradication, prokinetics, and central neuromodulators. There is currently no approved treatment for
functional dyspepsia. We have developed a noninvasive imaging method to simultaneously measure gastric
accommodation and gastric emptying, one or both of which are reported to be altered in up to 75% of patients
with functional dyspepsia. The approved NK 1 receptor (NK1R) antagonist aprepitant has been shown to
increase fasting gastric volume and postprandial accommodation in healthy participants without deleteriously
affecting gastric emptying. The novel NK1R antagonist, tradipitant, was previously shown to reduce symptoms
in patients with gastroparesis although the precise mechanism, overall effects, and benefit-risk ratio of this
medication unclear. Our general hypothesis is that tradipitant relieves symptoms in patients with functional
dyspepsia as well as enhances postprandial gastric accommodation without deleterious effects on gastric
emptying. Our aims are:
1. To compare the pharmacodynamics and clinical effects of tradipitant vs. placebo on satiation, fasting and
fed gastric volume, gastric accommodation, gastric emptying, and symptoms in patients with functional
dyspepsia (and non-delayed gastric emptying at baseline) based on Leuven Dyspepsia scale and Nepean
Dyspepsia Index
2. To assess prevalence of NKR-SNP rs881 genetic variant and the pharmacogenetics effects of this variant in
NK1 gene on the pharmacodynamics of tradipitant compared to placebo on fasting and accommodation gastric
volumes, gastric emptying and satiation.
In an exploratory analysis, we shall assess the correlation between gastric accommodation and emptying in
functional dyspepsia and to compare the relationship with those previously reported in health volunteers.
Anticipated Results and Significance: We expect these studies will lead to understanding the mechanisms
of action of tradipitant in improving gastrointestinal functions and patient reported outcomes, including pain, in
patients with functional dyspepsia, addressing unmet needs of millions of American citizens.

Public health relevance
PROJECT NARRATIVE / RELEVANCE 3 sentences We propose to study the effects of the NK1 receptor antagonist, tradipitant, on gastric function and symptom improvement in patients with functional dyspepsia. We will utilize and further validate simultaneous measurements of gastric emptying and gastric accommodation utilizing a solid meal and nuclear medicine scanning technique to better understand the pathophysiology of functional dyspepsia as well as the mechanism of action of tradipitant. Further understanding of the underlying gastric physiologic changes will provide groundwork for future diagnostic and therapeutic advances in functional dyspepsia.